Investigator Development Core

SUMMARY
Investigator Development Cores (IDC), while often sparse in flair or innovation, serve a vital role in fostering the
career development, mentoring and project support to early-stage investigators (ESIs). The PHSU RCMI IDC
was initiated five years ago. In its first phase, STategic Academic Research Training or START, we used prior
lessons learned in our earlier pilot project program, to mold a more successful approach to this important function
of training and supporting the next generation of high impact health disparities researchers. Those lessons were:
1. need for uniform training that covered important topics often overlooked in professional degree programs; 2.
the realization that mentoring teams could address the breadth of expertise needed by our ESIs; and 3. extending
pilot projects from one year to two in duration. START implemented several innovative strategies in addressing
these three points. We were notably successful in several of these areas. The monthly training and professional
development seminars had a positive effect on developing professional skills (assessed by surveys). Our
extension of the pilot project program to 2 years resulted in improved productivity: six pilot project awardees and
8 pre-pilot awardees representing a total investment of $635,000 from 2019-2024, produced a return-on-
investment factor of 5.16 generating $3.28 million in extramural funds. Of the full cohort of ESIs trained under
START (18 Scholars), there were 44 unique publications in the period of 2019-2023. Five of the 18 were
promoted in academic rank. One area where we did note substantial room for improvement was in the mentoring
aim – whether due to the COVID pandemic or other reasons, our Scholars did not document regular interactions
with their mentoring teams, although nor did they express dissatisfaction (by survey). In the second phase, now
called Strategic Pipeline for Academic Research Career Success (SPARCS), we will implement innovation by
addressing lessons learned in the first phase. The first aim becomes the START monthly training program, which
will include the innovation of incorporating continuity. Prior Scholars we be recruited as some of the presenters
in the monthly seminars. In the second aim, we have expanded the use of an Individual Development Plan in
conjunction with the mentoring team, which now includes a SPARCS leader to assure accountability and
effectiveness of the mentee’s relationship with the team in achieving IDP goals. Other novel aspects to the
mentoring aim are inclusion of a peer mentor (ideally a former Scholar) and a more direct link to the Community
Engagement Core (CEC). CEC is training cohorts of community members in research methodologies that are
available for mentoring teams and as collaborators for SPARCS Scholars. Our pilot project and pre-pilot project
programs will be similarly implemented as we are expecting to achieve similar results (5.16-fold return-on-
investment). Thus SPARCS is a combination of tried and true and novel approaches.

Public health relevance
The Investigator Development Core (IDC) strengthens the research workforce by supporting the training, mentoring, and career advancement of early-stage investigators engaged in health-related research. By improving research skills, nurturing effective mentoring, and providing structured support for pilot studies, the IDC promotes the development of high-quality and competitive research programs. These efforts contribute to the generation of scientific knowledge, the sustainability of the biomedical research enterprise, and the advancement of research aimed at improving health outcomes and population health.